Antibodies as Drugs: Innovative Formats, Design and Engineering

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Antibodies as Drugs: Innovative Formats,
Design and Engineering organized by Drs. Jean-Philippe Julien and Katherine Harris, with scientific
programming input from Keystone Symposia. The meeting will take place February 17–20, 2025 at Keystone
Resort in Keystone, Colorado, USA.
Antibodies have recently emerged as a mainstay therapeutic modality; new formats, combinations, and
innovative delivery methodologies promise to expand their reach to more diverse disease indications. This
meeting will showcase trailblazing approaches in the design and engineering of novel biologic modalities and
their impacts in pre-clinical development and outcomes in the clinic, especially for cancer, infectious diseases,
autoimmune diseases and diseases of the central nervous system. In addition to leading scientific sessions, the
conference will feature broader discussions around 1) an evolving landscape of regulatory considerations for
new biologics, and 2) the impact that Artificial Intelligence and machine learning technologies are having in the
field. Additionally, this conference will be held at the same time and location as another Keystone Symposia
conference, Drug Delivery to the Brain: Emerging Modalities, which will offer the unique opportunity for distinct
scientific communities with related interests to share cross-disciplinary insights and encourage new
collaborations towards novel treatment and delivery modalities that can be applied to prevent, treat, and cure a
multitude of diseases.

Public health relevance
PROJECT NARRATIVE Antibodies have enormous potential in the treatment of many diseases in humans and have emerged, along with other biologic drugs, as a therapeutic approach that is highly complementary to traditional small molecule-based drugs. Specifically, emerging scaffolds, potential combination therapies and innovative delivery methodologies promise to expand the reach of monoclonal antibodies (mAbs) as therapeutic agents. This meeting will showcase trailblazing methodologies, including the integration of artificial intelligence and machine-learning technologies, in the design and engineering of mAb therapeutics, ultimately improving patient outcomes across a wide range of medical conditions and diseases.